National Library of Medicine Conference 2022

Buffalo Research Innovation in Genomic and Healthcare Technology Education (BRIGHT
Education), University at Buffalo’s Department of Biomedical Informatics Post-and-
PreGraduate Research Training
The University at Buffalo’s Department of Biomedical Informatics, with funding from our first T15 grant, trained
3 PhD students and 6 post docs plus 8 short term trainees in biomedical informatics research. We continue our
focus on: 1-health & healthcare/clinical informatics; 2-translational bioinformatics; and 3-clinical research
informatics, with inclusion now on informatics of: 4) Public Health and 5) Consumer Health. The curriculum
builds on our growing MS and PhD programs with our existing faculty and outside mentors in addition to world-
renowned experts who provide workshops, etc. Most medical informatics focuses on the specifics of research
in implementation, technology, clinical care, etc. We do that, of course, but we also integrate the synergistic
research skills and orientations needed for biomedical informatics to move our discipline beyond its current
entanglements. In contrast, our department (now 7.5 years old) fits perfectly with the ethos and focus of the
NLM’s research training goals. We also realize that our location in a depressed area offers us the obligation,
opportunity, and privilege to recruit and train scholars so often excluded from this field. They can stay in
familiar settings, and bring their insights to others. Also, our affiliated scholars, researchers, practitioners, and
linked institutes will join with us to train and inspire our students. We enable students to use research to
understand and improve the field--analyze the complex interactions of workflow, evaluation, computer systems,
CDS, usability, ethics, big data, clinical research, and patient care–researching biomedical informatics to help
move healthcare IT to be a fluent, informed, and meaningful contribution to clinical efficiency and medical
knowledge. Our PhD program is comprised of core courses, required additional courses in 1 of the 5
concentrations (“selectives”), and at least 17 credits of electives. In addition to didactic and lab courses, all
students are involved in extensive research, practicums, workshops, presentations, mock IRBs and ethics
reviews, our EHR laboratory, patient safety and quality rounds, and human factors training. Because of
students’ varying expertise, we build in flexibility to reflect pedagogic requirements while ensuring mastery of
necessary skills and mentoring of students. Biomedical informatics continues to frustrate, despite (or because
of) its extraordinary promises. Only committed and skilled researchers can help us close this gap; enabling our
field to achieve what is so needed. We will work with the NLM to create an outstanding training grant meeting
program. We will serve as the local organizing committee for the meeting and will help recruit and host the
Scientific Planning Committee. We will accept and review applications and schedule the sessions. We will run
the meeting and host the meeting web site. During the meeting we will serve the needs of the participants and
host the meals and other functions including a welcome reception, a poster and networking reception and a
course dinner. We will offer optional trips on Friday to Niagara Falls for interested participants.

Public health relevance
The University at Buffalo Jacobs School of Medicine and Biomedical Sciences’ Department of Biomedical Informatics (DBMI) requests a supplement award for an administrative budget for the upcoming National Library of Medicine Conference 2022 that will be hosted in Buffalo, NY from June 22-24, 2022.